Deconstructing the multi-faceted roles of Rb in tumor progression

PROJECT SUMMARY
The Rb tumor suppressor is mutationally inactivated in relatively small fraction of lung
adenocarcinomas, but the Rb pathway in general is likely inactivated in the majority of cases. This scenario
sets the stage for therapies targeting the upstream negative regulators of Rb, namely cyclin dependent
kinases, to reactivate Rb's tumor suppressive functions. Currently, multiple clinical trials are underway to test
the efficacy of such therapies and significant clinical benefits have been discovered in certain cancer types.
However, even in these cases the therapeutic durability is uncertain and it is currently unknown whether Rb
reactivation will be effective in many other tumor types including lung adenocarcinoma. Adding to this
uncertainty is the surprising realization that the role of Rb, or the Rb pathway in general, in oncogenic Kras-
driven lung adenocarcinomas is unclear. Therefore, our project has two major goals: Aim 1 focuses on
determining the functional consequences of Rb mutations in both genetically engineered mouse lung
adenocarcinoma models and in human lung cancer specimens. In contrast, Aim 2 of this proposal focuses on
modeling Rb reactivation therapy using a genetic tool recently developed in our laboratory that allows both, the
conditional inactivation of Rb during tumor development, and the inducible and accurate reactivation of Rb
once cancers are established. Fueled by our preliminary findings, our overarching hypothesis in Aim 1 is that
loss of Rb accelerates lung adenocarcinoma progression by removing two distinct barriers that work in
sequence to limit the adenoma-carcinoma transition, and then the onset of metastatic competency. In Aim 2,
our initial insights suggest the hypothesis that the major role of Rb restoration in established lung
adenocarcinomas is to reestablish repressive chromatin structures that lead to the reversal of advanced tumor
grades and repression of pro-metastatic gene expression programs.
We expect that our study will uncover the mechanisms that drive selection of Rb pathway mutations,
and establish the therapeutic efficacy of Rb pathway restoration in lung adenocarcinoma. Further, our study will
highlight specific biochemical programs utilized by the Rb pathway in disease relevant contexts that could be
therapeutically stimulated to recapitulate the natural functions of this critical tumor suppressor. These insights
may be broadly applicable to the many tumor types that harbor Rb pathway mutations.

Public health relevance
PROJECT NARRATIVE The cellular control pathway regulated by Rb becomes dysfunctional in the majority of lung adenocarcinoma cases yet the reasons these mutations are selected remain unclear. Emerging therapeutic strategies aim to reactivate the Rb pathway to treat cancer, however, it is still not known whether restoration of Rb pathway would be efficacious, or how Rb would mechanistically effectuate an anti-tumor response. The overall goals of this proposal are: 1) to identify the selective advantages that Rb mutations provide during lung adenocarcinoma progression, and 2) to establish the therapeutic efficacy of restoring Rb gene function in advanced stage lung adenocarcinomas and identify the mechanistic basis of Rb-mediated tumor suppression.